Increasing capacity and capability of shared biochemistry/biomedical science instrumentation through acquisition of modern, high-speed centrifuges

Project Summary
This proposal requests the acquisition of Avanti JXN26 centrifuges equipped with rotors to modernize the
Biochemistry Protein Production and Purification (BioP3) Core at Georgia Southern University (GS). Access to
these modern centrifuges with increased capabilities including higher speeds (up to 80,000 rcf) and higher
capacities (up to 6 x 1 L) than existing centrifuges within the core will tremendously enhance the research
capabilities of BioP3 users, as well as increase the productivity and efficiency of the current users of this shared
research core. The core is housed in the Department of Biochemistry, Chemistry, and Physics (BCP) within the
College of Science and Mathematics (COSM). The COSM Core Research Laboratories (CCRL) is a collection
of core services and high-end instrumentation that help maintain and manage shared instrumentation across the
college. BioP3 works within the CCRL model ensuring that there is continued support such as in terms of
maintenance and daily operations and promoting the use of core services within the college. Currently, the BioP3
core primarily is used in the production of soluble proteins and pelleting of bacteria for various applications
serving primarily biochemists and biomedical scientists within BCP and the Department of Biology. The PI, lead
of BioP3 and one of the major users of the core, is an NIH-funded structural biologist in the area of cancer drug
discovery. Three other-NIH funded investigators will be directly affected by this modernization. The production
and high purity recombinant proteins is critical in several areas of biomedical research including structural
biology, protein engineering, and drug discovery. Thus, the immediate goal of this proposal is to improve the
support infrastructure for current users by providing the core with up to 6-fold theoretical improvement in its
efficiency. Acquisition of these centrifuges also immediately enables areas with urgent needs including research
involving isolation of membrane proteins and subcellular organelles and purification of viral particles. Current
researchers in these areas actively seek NIH, NSF, EPA, and DoD funding and a modernized support facility will
only improve their ability to compete for these grants. The long-term objectives of this proposal are i) to ensure
the continued success of currently funded investigators, ii) to better support the research of early career
investigators (two of the NIH-funded PIs are ECI), iii) to enable other high-impact research currently not
accessible with limited centrifugation capabilities, and iv) to contribute to the success of the biomedical research
enterprise within Georgia Southern University and the Southeastern region of Georgia. Modernization of BioP3
is in line with the current growth in the biomedical space at GS including the opening of the medical school (with
Medical College of GA), the BS in Biomedical Sciences in Fall 2025 (and a planned PhD by Fall 2026), and other
initiatives that aim to support and enhance biomedical research in South Georgia.

Public health relevance
Public Health Relevance Statement. The Biochemistry Protein Production and Purification Core at Georgia Southern University enables investigators in the biochemical and biomedical sciences to pursue high-impact research in areas such as structural biology, drug discovery, and protein engineering. This proposal aims to modernize this core and improve its capabilities by requesting the purchase of two high-speed centrifuges with various rotors serving different applications. Success of this proposal will ensure continued support of current researchers, improve their capabilities and invite the use from other users, optimize and maximize the productivity of future users, and increase the research outcomes in high-impact areas of biomedical research.